Cornell program to increase faculty diversity and promote research excellence

Project Summary/Abstract
Diversity increases creativity in problem solving endeavors like biomedical research. Diversity of educators also
improves the success of students from underrepresented groups. Thus, increasing the recruitment and retention
of underrepresented minority (URM) faculty will directly increase diversity of the biomedical workforce, and
increase the likelihood that current minority undergraduates, and graduate students, enter the US biomedical
workforce. Cornell has successfully implemented programs that have increased diversity of undergraduate and
graduate students, and that have increased representation of women in the biomedical research faculty. We now
propose programs that will increase representation of minority faculty with research programs aligned with the
NIAID mission. The overall goals of this program are to: 1) increase the diversity of our faculty, 2) build supportive
interactions among participants, 3) provide mentoring and professional development opportunities to early career
faculty (ECF) so they reach full potential as scholars, teachers, and contributors to their department, college and
the university, and 4) create a culture of acceptance in inclusiveness to increase retention of URM at Cornell.
We will reach these goals with four specific aims. Aim 1. Provide a grant-writing course and skills development
workshops to support the participant’s academic success. Aim 2. Create a visiting scholar grant to enhance the
participant’s NIAID-related scholarship. Aim 3. Develop multiple forms of mentoring, and mentor training, to
increase the likelihood of the participant’s long-term success in biomedical research. Aim 4. Increase the diversity
of faculty applicant pools and percentage of URM faculty hired. Overall, the programs outlined in this proposal
will directly increase diversity of the biomedical research workforce at Cornell University, and will have more
broad effects indirectly by creating a group of successful URM faculty who can inspire and train the next
generation of increasingly diverse undergraduate and graduate students.

Public health relevance
Project Narrative Increasing diversity in the biomedical workforce increases the impact of science, and is critical to address as the demographics in the US continue to become more diverse. While programs to increase diversity in undergraduate and graduate students have been very successful and should be maintained, diversity of academic faculty remains low. This program is specifically designed to increase ethnic, racial and overall diversity of the NIAID-mission-related faculty researchers at Cornell and provide programs to promote their success as well as that of other early career biomedical research faculty.